Administrative Supplement to the Existing Oklahoma INBRE Award

Project Summary
This Administrative Supplement proposes continuation of all major activities of the OK-INBRE program for an
additional 10 months (5/1/24 – 2/28/25), including the Administrative Core, Bioinformatics Core, Proteomics
Core, Developmental Research Project Program (continuation of current active Research and Pilot Project
Leaders) and Alteration and Renovation. This supplemental application for the Oklahoma IDeA Network for
Biomedical Research Excellence (OK-INBRE) outlines how we will further enhance the statewide research
infrastructure and biomedical research capacity in Oklahoma by: (i) enhancing and strengthening the research
culture and building biomedical research capacity and research infrastructure at network institutions; (ii)
providing support for faculty research and research mentoring to strengthen biomedical research excellence and
expertise throughout Oklahoma; and (iii) providing research opportunities for students to help develop a strong
biomedical research workforce in Oklahoma. The statewide OK-INBRE network includes two research intensive
institutions, Langston University, the only Historically Black University in Oklahoma, and Northeastern State
University, a PUI with one of the highest numbers of American Indians of four-year colleges in the nation.
Additionally, Oklahoma’s only accredited tribal college, along with four other PUIs and three additional community
colleges are included that educate large numbers of students from underrepresented groups. OK-INBRE will
provide continuation of six significant research project investigator (RPI) awards that are currently approved.
Specific career development mentors will help the RPI awardees achieve scientific independence. In addition,
currently approved pilot project grant awards will continue for five PUI pilot project awardees. Equipment awards
will be provided through a peer-reviewed grant selection committee for PUI and CC applications. Support for 35
undergraduate students also will be supported through a vibrant and dynamic summer undergraduate research
program. OK-INBRE will also support Bioinformatics and Proteomics Core facilities that will serve as statewide
research and educational resources to provide faculty, trainees, and students throughout the state with access
to the computational tools needed to enhance multidisciplinary biomedical research in Oklahoma. Uniquely, the
Proteomics Core will not only play a central role in training the next generation of researchers in Oklahoma, but
it will also be used as a resource for investigators in all IDeA-eligible states. An alteration and renovation project
at TCC will be undertaken to enhance and expand student training by transforming currently unused space into
new laboratory and experiential teaching facilities. Finally, through an undergraduate research program; multiple
workshops and seminars; research mentoring; and access to state-of-the-art core facilities; the OK-INBRE
program will continue to enhance statewide infrastructure and research capacity while training the next
generation of Oklahoma’s biomedical research workforce.

Public health relevance
Project Narrative The Oklahoma INBRE (OK-INBRE) program supports biomedical research and allows researchers in Oklahoma to be more competitive for federal research funding that leads to better medical diagnostics and novel therapies to treat human disease. OK-INBRE also enhances the pipeline of undergraduate and graduate students choosing careers in biomedical research to ensure there will be well-trained biomedical scientists in Oklahoma and throughout the country for future generations. The overall goal of the OK-INBRE program is to support faculty research and research mentoring, student participation in research, and enhancement of institutional research infrastructure.